Stress and Resilience in the VIP

Asian Americans are the fastest growing racial minority group in the U.S and yet there is a dearth of
research on their cognitive aging and risks for Alzheimer's disease and related dementias (ADRD). This
is especially true for Vietnamese Americans, the 4th largest Asian American group in the U.S.
Vietnamese Americans suffer disproportionately from early life adversity and trauma, depression,
stress, and low socioeconomic status (SES), all of which may increase risk for cognitive impairment
and development of dementia. The specific sociocultural context of this group (i.e., high exposure to
trauma, stress, diverse acculturation and immigration patterns) provides a unique opportunity to
examine how early life factors and sociocultural diversity impact cognitive outcomes. In this supplement
application, Stress and Resilience in the VIP (parent grant: Vietnamese Insights into Cognitive Aging
Program (VIP), R01AG067541), we will build on this unprecedented cohort study by collecting
additional and innovative data. The overall goal of the parent grant is to obtain preliminary estimates of
mild cognitive impairment and dementia in the community and identify ADRD risk and resilience factors
in this understudied group. For this supplement, we propose the following: Aim 1: Obtain measures of
stress and resilience in VIP participants at their Time 2 visit. We will add two additional measures
not yet captured in the grant but are important within the context of cognitive aging for Vietnamese
Americans– perceived stress and resilience, and hs-CRP will be added to the blood draw (N = 540).
Aim 2. Examine the associations between stress, trauma, and adversity. We hypothesize that
those with increased levels of perceived stress and hs-CRP at Time 2 will have reported higher levels
of trauma and adversity at the Time 1 visit. Aim 3. Examine the associations between new
measures and cognition. We hypothesize that those with elevated levels of perceived stress and hs-
CRP will have lower cross-sectional cognition scores, and this relationship will be attenuated by higher
resilience scores. This proposal contributes new research to an unmatched longitudinal study whose
findings will lead to a better understanding of cognitive aging and mechanisms of disease in an
understudied group but also have broader implications for advancing our knowledge of the sociocultural
and early life contributions to cognitive aging in other populations.

Public health relevance
PROJECT NARRATIVE As the number of Asian Americans continues to grow faster than any other racial/ethnic population in the U.S., so too will the number of those with Alzheimer's disease and related dementias; yet very little is known about their risks for cognitive impairment and dementia. This study will add new and innovative data to an unprecedented study of Vietnamese Americans at risk for dementia. Understanding the nuanced roles of life course stress and trauma in a high disparity group has significant implications for understanding risk and resilience factors in all individuals.